Ethical, multimodal AI tool for prediction of preeclampsia risk in early pregnancy

Project Summary/Abstract
We aim to develop an ethically-centered, data-driven multimodal AI tool to predict preeclampsia
risk in early pregnancy. As preeclampsia is a major contributor to the rising maternal and fetal
morbidity and mortality, and there are significant racial disparities in care, our approach can
revolutionize pregnancy care. We will use data from the electronic health records, encompassing
structured (demographics, comorbidities, vital signs, labs, and medications) data, ultrasound
images, and unstructured text (physician notes) of 202,485 individuals from Mass General
Brigham. We will add polygenic risk scores for a subset of those individuals, which are available
through a biobank linked to the medical records. We propose a novel, time-aware embedding to
develop our multimodal AI tool for decision support in early pregnancy. Subsequently, we will
utilize transparent techniques and bias mitigation to ensure equitable care. We will rigorously
evaluate the performance of the novel model in external datasets from NuMom2b, AllOfUs, BCC-
Preg, and University of Washington cohorts, consisting of more than 50,000 patients. We will work
with ethics and human factors research experts throughout the model development stages and
implement an ethics-informed framework to ensure we consider all relevant stakeholders’ needs.
We have assembled an expert, cross-disciplinary team with all available state-of-the-art resources
within the Harvard Medical School, Boston hospitals, and external collaborators, making us ideally
suited to carry this work forward. Ultimately, we aim to validate and implement these tools in
clinical practice, leading to a greatly enhanced ability to identify high-risk patients early and
improve patient safety.

Public health relevance
Preeclampsia is a serious pregnancy complication that contributes substantially to maternal and neonatal morbidity, and earlier identification of patients at risk could support preventive strategies such as aspirin prophylaxis, home blood pressure monitoring, and closer clinical surveillance. This project develops and validates an ethics-informed multimodal AI tool that integrates early pregnancy EHR data, clinical text, ultrasound imaging information, and genetic risk to improve preeclampsia risk prediction while incorporating patient and clinician perspectives on safety, transparency, trust, and responsible use.